Data Center for Acute to Chronic Pain Biosignatures

Project Summary
The Acute to Chronic Pain Signatures (A2CPS) study is generating a rich longitudinal dataset that includes
clinical, behavioral, biospecimen, and neuroimaging data aimed at identifying biomarkers that predict the
transition from acute to chronic pain. While this dataset holds tremendous potential for advancing pain research,
its complexity and scale pose substantial barriers to access, especially for researchers without technical or
computational expertise. To address this problem, we propose to develop a domain-adapted large language
model (LLM) that allows users to query the A2CPS dataset using natural language. This system will be fine-
tuned using both structured metadata and unstructured documentation to ensure semantically accurate and
interpretable responses. We will build a user-friendly web interface to support dynamic querying, hypothesis
generation, and exploratory data analysis, with outputs including summary statistics, data descriptions, and
visualizations. Validation will focus on accuracy, usability, and impact on research efficiency, particularly for non-
technical users. This work will improve the accessibility and utility of the A2CPS dataset, support more equitable
data-driven research, and establish a generalizable framework for LLM integration with other large-scale
biomedical data resources.

Public health relevance
Project Narrative Chronic pain is a leading cause of disability and a major public health concern. The A2CPS study was created to identify biomarkers of chronic pain risk, but its impact depends on broad and effective data access. This project will develop a large language model–based system that allows researchers to explore A2CPS data using natural language, making the dataset more accessible to a wide range of investigators and accelerating discoveries that can ultimately improve pain prevention and treatment.